Long-range inhibitory neuron circuit organization and cortical function

Project Summary
Cortical activity is highly dependent on behavioral state of an animal with different states, such as sleep and
wake, having profound impact on cognition and cortical processing. At the brain level, behavioral states (such
as sleep and wakefulness) are associated with distinct patterns of cortical activity (or cortical states), that are
well captured by oscillatory activity measured with EEG and/or LFP. Recent work shows that cortical states
regulate processing of local neuronal information as well as the communication between brain areas, and despite
this important function, relatively little is known about the circuits underlying these distinct states of network
activity. Inhibitory neurons (INs), though they make up a minority of cells in the cortex, are well positioned to
regulate cortical state. While the vast majority INs in the cortex project locally, there is a subtype of cortical IN
that projects over a long distances in stark contrast to other INs. These cells arborize densely throughout the
cortex, can span over different cortical regions, and are remarkably unique in terms of gene expression and
morphology. Even though they constitute a very small portion of INs, they are evolutionarily conserved,
suggesting that these cells play an important role in brain function. Their massive axonal arborization suggests
that these cells can coordinate the activity of many downstream cells. Though this IN cell type is completely
unique in its morphology and potential role in cortical circuits, we do not understand its function, though, I
hypothesize it is crucial for regulating synchronized slow cortical rhythms. Here we will use new intersectional
genetic tools in the mouse, to gain access to this distinct neuronal type and to interrogate the in vivo functional
role of SST/nNOS INs in cortical circuits. The long projections and dense cortical arborizations of SST/nNOS
cells make them a good candidate to synchronize activity across large areas. Furthermore, ex-vivo studies
suggest that long-range inhibitory neurons are likely to be active during periods of highly synchronized brain of
slow wave sleep (SWS). This state is characterized by a slow oscillation between UP and DOWN states that is
tightly synchronized across millimeter distances in the cortex. While many believe transitions between UP and
DOWN states arise solely from interactions between pyramidal cells, recent work suggests that an unknown
mechanism exists to initiate the sharp and synchronous DOWN state transition across millimeter areas. I
hypothesize that the activity pf SST/nNOS cells is critical for the generation of slow cortical rhythms and the
transition from UP to DOWN states.

Public health relevance
NARRATIVE The proposed research is relevant to public health because it will provide novel insights into the role of long-range inhibitory neurons in different states of cortical activity that occur during sleep and wakefulness. This research will be significant because it will clarify the mechanisms by which the firing activity of a specific type of long-range inhibitory neuron influences cortical states in health and in disease. This is relevant to the NIH mission to seek fundamental knowledge of the visual system and to use this knowledge to reduce the burden of neurological disease.